CHANGES IN SLEEP STATE RESULTING FROM ABRUPT ALTERATIONS IN ARTERIAL PRESSURE

This study will investigate the effects on sleep state of abrupt changes in arterial pressure. Sleeping normal subjects will be exposed to pharmacologic manipulations of arterial pressure and sleep will be monitored.